Interdisciplinary Training Program in Lung Research

PROJECT SUMMARY
Acute and chronic lung diseases are major causes of morbidity and mortality throughout the world. For many
of these diseases, the fundamental pathobiology is not well understood and effective disease-modifying
treatments are not available. This training program titled “Interdisciplinary Training Program in Lung Research”
focuses on training researchers in basic mechanisms of lung disease and is committed to equipping young
investigators with the skill set necessary to develop into successful researchers and academic leaders. The
Division of Allergy, Pulmonary, and Critical Care Medicine at Vanderbilt University and the Vanderbilt Center
for Lung Research (VCLR) have a long, successful history in developing well-trained researchers who have the
vision and the skills with which to embark on successful research careers. This program is housed in the
VCLR, which was developed to coordinate and enhance collaborative interdisciplinary research and training.
Dr. Timothy Blackwell (director of the VCLR) serves as program director. The program is designed to support
post-doctoral trainees (both M.D. and Ph.D.) who show exceptional aptitude for successfully pursuing an
academic research career. Trainees concentrate on one of five disease focused areas of existing expertise in
the VCLR: acute lung injury and host defense, asthma and airway disease, interstitial lung disease, pulmonary
hypertension, or lung cancer. A customized mentoring team is formed for each trainee, consisting of a mentor
with nationally recognized expertise in the area and a research advisory committee to provide additional
guidance, mentoring, and feedback. The trainee's experience is enhanced by interactions with other
investigators and trainees in existing lung disease-focused research programs in the VCLR, an extensive
program of seminars and conferences, and coursework tailored to meet the needs of each trainee. As a result,
each trainee develops an understanding of the translational paradigm in his/her area of research and attains
the academic skills necessary to become a future leader in the field of lung research.

Public health relevance
NARRATIVE While there are unprecedented opportunities for advancement in understanding of the fundamental mechanisms of lung diseases, the pipeline of new investigators who are trained and committed to careers in lung disease-oriented biomedical research is inadequate. This interdisciplinary training program is designed to meet this challenge by preparing future leaders in lung research to advance science and improve health.